Training in Immunological Mechanisms

Abstract
This program will train postdoctoral research scientists in immunological mechanisms related to development
and treatment of Autoimmune, Inflammatory, and Infectious Disease, and Cancer. The program at La Jolla
Institute for Immunology (LJI) will involve 20 faculty members from LJI whose expertise is in immune cell
function that relates to diseases such as diabetes, inflammatory bowel disease, multiple sclerosis, asthma,
atherosclerosis, atopic dermatitis, dengue, HIV, cytomegalovirus, tuberculosis, ebola, and immuno-oncology.
Each faculty mentor is internationally recognized in the field of immunology or immunological disease and each
has substantial peer-reviewed research experience and track records. The program will be open to PhD, MD,
and MD/PhD scientists interested in basic and applied research of the immune system. The training program
will consist of a bench research laboratory experience of 12-24 months, under the close supervision of a
mentor or several mentors working on problems relevant to immunotherapy. The research backgrounds of the
faculty mentors are diverse, but with common themes centered on the biology of the primary cells of the
immune system, including T cells, B cells, NKT cells, macrophages, dendritic cells, neutrophils, and others.
The training program will then represent an interdisciplinary approach where each trainee is exposed to cutting
edge and state-of-the-art immunological techniques and systems for making fundamental and translational
discoveries of the immune system. Our current and past trainees have excellent records of research
accomplishments. New trainees will be recruited nationwide and efforts will be made to recruit and retain
exceptional minority, women, and disadvantaged candidates. Trainees will be chosen on the basis of their prior
academic performance, research experience, publications, interviews, and recommendations from supervisors.
Trainees will participate in institutional seminars, journal clubs, courses, and immunology conferences
designed to expand the breadth of their understanding of immunology and immunological disease. All trainees
will be instructed in the principles of responsible conduct of research and scientific integrity. The goals of the
program are to foster the development of well-rounded immunologists who can fill much needed academic
positions, who can compete and be successful in obtaining independent research grants, and who can
contribute to biotechnology and pharmaceutical approaches, aimed at treatment of immune-related diseases.

Public health relevance
Narrative Immunological diseases affect millions of people in the United States. There is a great need for PhD and MD scientists to advance our understanding of immunologic mechanisms related to autoimmune, inflammatory, and infectious disease, and cancer, and to translate findings from bench to bedside. The program will train future academic and industry leaders in approaches relevant to understanding how to modify the immune system to improve health.